DEVELOPING AFFINITY MASS SPECTROMETRY AND

Successful coupling between affinity purification and matrix-assisted laser desorption has been achieved. The method can be applied for a variety of biomedical that involve as molecule-molecule interactions (ligand-receptor, protein-DNA).